Global Center on Climate Change and Water Energy Food Health Systems - Administrative Core

Abstract – Admin Core
the Global Center on Climate Change and Water Energy Food Health Systems (GC3WEFH) is a program with
multiple components and a multidisciplinary team of scientists supporting the general goal of addressing climate
change health impacts among the most vulnerable global communities. In order to have an effective impact, the
center requires an organized core dedicated to coordination of its components to support each other, have fiscal
oversight, and ensure timely decisions during the period of the program. The Administrative Core (AC) will be
the core responsible for this role by connecting all the components of the GC3WEFH that will allow Data Services
Core, Research Engagement Core, and Research Project teams to function as one comprehensive whole.
Center research activities will take place in the Azraq Basin, one of the most climate vulnerable regions within
Jordan, and will involve well-defined groups of communities that the Center will reach through strategic
community-level partnerships. In addition, the AC will foster each Core’s efforts at capacity building to sustain
successful interventions and expand the implementation of solutions and the resources generated by the center.
The AC will have a leadership organization structure to allow everyone the ability to follow how decisions are
made, and who is responsible for which part of the Center. This is extended to the community organizations and
partners the center will engage for the different aims of each core. The research quality, integrity and consistency
of research methods, and level of productivity is also part of the role of the AC to maintain the high standards of
the evidence and the interventions that can be built based on such evidence. The AC will also be responsible for
administration of the pilot funding to community partners, which is an important component for the community-
academic partnerships for the center in this period and future scale up. There will be an External Advisory Board
of expert scientists and Stakeholders Advisory Board of Community organizations that will be engaged in
developing the agenda for the center and addressing any challenges that the center and its components might
face. Community engagement is central to the function of the center, and there is a very strong tie to the
Community Engagement Core by having the Overall Director of the Center be also the lead of the Community
Engagement Core. The Executive Committee is formed of the lead members of all participating universities as
well as the local community leader. The Director and Deputy Direction are both culturally and linguistically
connected to the region and its people and have had a long history of research funded by NIH and NSF within
such settings, which will strengthen the Center’s networking capacity and impact during this funding cycle and
future ones. This effort will be carefully evaluated by a dedicated team of experts and providing direct feedback
to leadership on regular basis to refine the aims and activities based on such evaluation. The development of
the AC is to serve the center for this funding period and potential future ones after this exploratory phase.